Training Grant In Tumor Biology

The overall mission of the Tumor Biology Training Program (TBTP) at Georgetown University (GU) is to provide our pre-doctoral trainees with in-depth knowledge and understanding of the basic molecular mechanisms that underlie tumor initiation and progression, as well as with the basic principles of cancer therapy and its translational applications. This highly successful graduate training program is the only NCI-funded pre-doctoral training program at Georgetown University (GU) and is the only GU training program dedicated to cancer research. The goal of the program is to provide not only a rigorous training platform, but also T32-dedicated research/training resources, including a personalized program for career development deeply integrated into numerous educational and networking opportunities. This renewal application incorporates a new leadership structure with the addition of Dr. Chunling Yi as part of a multi-PI team with the current PI, Dr Anna Riegel. We request support for 6 predoctoral trainees who will participate in an individualized training program consisting of integrated research, course work, workshops, programmatic activities, exposure to clinical/translational aspects of cancer, professional/career development, networking opportunities and engagement with cancer advocates. The 35 TBTP faculty are drawn from the three highly interactive programs, Cancer Cell Biology (CCB), Cancer Host Interaction (CHI) & Cancer Prevention and Control (CPC) of our NCI-designated Lombardi Comprehensive Cancer Center (LCCC). These programs reflect emerging themes in tumor biology, which include an enhanced focus on tumor immunology, epigenetic regulation, mechanisms of therapy resistance, as well as cancer prevention and control. The LCCC integrated environment stimulates interdisciplinary collaborations, co-mentoring opportunities, and translational initiatives. The TBTP has experienced much success over its 27-year history. For the next funding period, we will continue to address the changing landscape of cancer research through constant assessment and evolution of our program. We have incorporated a number of new initiatives designed to provide new opportunities for cutting edge research, data analysis, translational emphasis and individualized learning coupled with professional development and wellness support of all our trainees. Going forward we have also enhanced our rigor and reproducibility and mentor training. We will continue to challenge ourselves in all aspects of TBTP training consistent with the NCI mission of “supporting cancer research across the nation to advance scientific knowledge and help all people live longer, healthier lives.”

Public health relevance
The Tumor Biology Training Program (TBTP) is designed to prepare the next generation of dynamic cancer researchers with lifelong learning skills so that they can make significant inroads into the understanding, prevention and treatment of cancer and to advance scientific knowledge so that all of our cancer patients can live longer and happier lives.